Training Program in Cognitive Neuroscience

DESCRIPTION (provided by applicant): The goal of this training program is to provide advanced graduate students and postdoctoral fellows with interdisciplinary training in cognitive neuroscience and to create a new generation of cognitive neuroscientists devoted to the study of normal and abnormal brain function. San Diego has an extremely active research community in cognitive neuroscience, and 23 faculty members from the Salk Institute for Biological Studies and at UCSD participate in this training program, including 7 new faculty since the last renewal of this program. The graduate students will be enrolled in graduate programs in the Departments of Cognitive Science, Psychology, the Neurosciences Graduate Program and the Division of Biological Sciences. The predoctoral trainees will be engaged in thesis research, and the postdoctoral trainees will be engaged in new research projects aimed at developing new approaches to understanding cognitive brain functions. The administrative structure of the proposed program comprises an Executive Committee with co- Directors T. Sejnowski (Salk and UCSD) and S. Hillyard (UCSD), and members T. Albright (Salk). U. Bellugi (Salk), J. Elman (UCSD), M. Kutas (UCSD), and L. Squire (UCSD). The four major areas of research of the faculty are sensory processing and perception, selective attention, learning and memory, and cognitive control. The laboratories that will participate in the proposed training program have a long history of research collaborations. Training will be provided in a wide range of techniques including electrophysiology, magnetoencephalography, functional magnetic resonance imaging and computational modeling. Major research facilities include the UCSD/Salk Functional MRI Center, the Multimodal Imaging Laboratory, the Radiology Imaging Laboratory and the Motion Capture/Mobile EEG Laboratory. The current training program supports 4 predoctoral and 4 postdoctoral trainees. Given the significant increase in the number of qualified applicants and the availability of major new facilities for pursuing research in cognitive neuroscience at UCSD, for this renewal we are requesting support for 6 predoctoral and 6 postdoctoral trainees. The Office of Graduate Studies at UCSD has pledged a matching fellowship for minority predoctoral student.